Meharry Medical College-Community Health Centers Network

The Meharry Medical College-CommunityHealth Centers (CHCs) Community Networks Program (CNP) is a component of the Meharry Center for Optimal Health. Its purpose is to reduce cancer health disparities among African Americans by conducting community-based participatoryeducation in six urban and rural communities in Tennessee (Nashville, Chattanooga, Memphis), and Mississippi (Jackson, Canton, Mound Bayou). Overall program goals are to significantly improve access to and utilization of beneficial cancerinterventions in these six CHC communities, and provide a cadre of well-trained researchers who continue to reduce disparities in these communities. The CNP will be implemented in three phases over five years, hi Phase I (Year 1), an umbrella coalition of organizations and individualswill be formed to begin making joint plans for communitynetworking activities, and to develop an infra-structure that facilitates research participation in the target population. Meharry will be the Coordinating Center. A Steering Committee will meet annually at Meharry, and Regional Committees representative of their communities will meet at five sites on a monthly basis. These committees will be advised regularlyby persons from the target population that are knowledgeable of the community and of the problem of cancer. Furthermore, collaborations will be formed with academic, governmental, and other key organizations that can contributeto the development and implementation of quality research methods. A Logic Model has been developed to provide operationalguidelinesacross all sites. Training in community-basedand other methods will occur at all levels of personnel, including new, especially minority, investigators. In Phase II, program development will occur, using the Logic Model and community-based participatory guidelines, as well as guidelines from other management and behavioral models. In Phase HI, funding will be sought to sustain credible beneficial programs on a large scale.